Molecular mechanisms of histone signaling in a chromatin relevant context

Project Summary
The human genome exists in the cell nucleus as chromatin, a complex of the DNA with histone proteins.
Though genetic information is encoded in the DNA sequence, another layer of information, is encoded in the
histone proteins, specifically in the form of post-translational modifications (PTMs). This layer of information is
often referred to as epigenomics, and provides instructions on how the genome is to be regulated. Chromatin
and the epigenomic content, is highly dynamic, constantly restructuring in response to developmental and
environmental cues. One of the most important questions in biology is how this information is interpreted by
transcriptional and other regulatory complexes, leading to gene regulation and cell fate. Histone modifications
are “read” through small subdomains within the regulatory complexes called reader domains, and specificity for
a unique epigenomic pattern is thought to be achieved through the integrated activity of multiples of these
reader domains. However, though much is known about the association of reader domains with fragments of
histones, the molecular mechanims underlying how they associate with histones in a chromatin relevent
context, or how they function together to readout a specific epigenomic state, are not well understood.
This research program addresses this fundamental question in chromatin regulation. We are pioneering the
use of NMR spectroscopy to study the association of reader domains with the basic unit of chromatin, the
nucleosome. We are combining this with fluorescence microscopy, cryo-electron microscopy, and basic
biochemistry for an overall multidisciplinary approach to building models of these complexes. Over the next five
years we will focus on how the conformation of the nucleosome regulates readout of epigenomic signatures.
We will continue our investigation of the nucleosome conformation itself and how known cancer mutations
dysregulate this. In addition, we will determine the kinetic and structural basis of association of reader domains
from the PBAF chromatin remodeling and PRC1 histone modifying complexes with nucleosomes. Through
collaborative studies we will investigate the functional consequence of these interactions. We will continue to
build towards our long-term goal of understand of how multiple reader domains integrate to allow regulatory
complexes to navigate and respond to a dynamic chromatin substrate. Results from this research program will
reveal fundamental mechanisms of chromatin regulation, provide insight into the etiology of a number of
human diseases, and lay the groundwork for the development of targeted therapeutics.

Public health relevance
Project Narrative Chromatin mediated regulation of the genome is critical in human development and health, and dysregulation of chromatin remodeling processes is associated with a large number human pathologies including developmental disorders, cardiovascular disease, cancer, auto-immune disease, and neurological and psychiatric disorders. This proposal seeks to determine mechanisms of chromatin structure regulation by defining the molecular details underlying how regulatory complexes navigate chromatin. Results will provide significant insight into processes of genome regulation, the etiology of human disease, and lay the groundwork for the development of targeted therapeutics.